Rapid Real-Time Cardiovascular MRI for Detecting Coronary Artery Disease

Project Summary/Abstract: Coronary artery disease (CAD) is a leading cause of sickness and death in the US. Noninvasive cardiac imaging plays a vital role in diagnosing, risk stratifying, and guiding treatment decisions in patients with known or suspected CAD. However, the limitations of current imaging strategies are well documented. In a previous study of nearly 400,000 patients without known heart disease undergoing elective cardiac catheterization following a positive pre-test (mostly stress echocardiography and nuclear perfusion imaging), approximately 60% of them were found to not have obstructive CAD. According to recent AHA guidelines, radiation risk is an important consideration when choosing a diagnostic test. Indeed, there is an unmet clinical need to advance radiation-free diagnostic imaging tests for accurate diagnosis of functionally significant obstructive CAD. Since no single test is 100% accurate, one cost-effective approach to increase accuracy is to perform a comprehensive assessment within a single modality. Among available cardiac imaging modalities, MRI is arguably the most versatile and capable of a comprehensive evaluation of CAD, including cardiac function, perfusion, coronary angiography, and viability, while not requiring ionizing radiation. Despite substantial successes from both basic research and clinical trials, and even after decades of advancements, cardiac MRI continues to be hampered by (i) long exam times (~ 60-90 min), (ii) complexities in operation such as breath- holding requirements, and (iii) poor performance in patients with arrhythmias. To overcome these obstacles, we will develop a rapid (15 min), real-time (arrhythmia and motion insensitive) cardiovascular MRI protocol that can be performed during free breathing, while producing diagnostic accuracy comparable to a standard clinical MRI protocol (60-90 min). The central hypothesis of this application is that a rapid (15-min) MRI protocol produces diagnostic accuracy comparable to a standard clinical MRI protocol. The specific objectives in support of testing our central hypothesis are: (1) to develop rapid image acquisition and reconstruction methods that will be integrated into a single protocol streamlined for detecting CAD and (2) to evaluate the agreement between rapid and standard MRI results. This study leverages extensive clinical and research resources existing at Northwestern University (~200 cardiac stress MRI scans per year; cardiovascular imaging research). A rapid, free-breathing MRI protocol is a major step forward in MRI technology, because it will dramatically increase scan efficiency, simplify scan operation, and reduce financial burdens for imaging centers with limited expertise and resources to offer cardiovascular MRI as a routine clinical service. Success of this 3-year R01 application will yield preliminary data needed to pursue a renewal application aimed at validating diagnostic accuracy of a rapid MRI protocol against catheter X-ray angiography in a diverse population at multiple sites.

Public health relevance
PROJECT NARRATIVE: Despite substantial success from basic research and clinical trials, and even after decades of advancements, cardiac MRI continues to be hampered by long scan times (~ 60-90 min), complexities in operation such as breath-holding requirements, and poor performance in patients with arrhythmias. This proposal seeks to develop and test an innovative MRI technology that will address the aforementioned obstacles and cause a paradigm shift in cardiovascular MRI: from lenghty breath-hold scanning to rapid, free-breathing scanning. Success of this application will accomplish two important objectives: (i) produce a rapid (15-min) MRI protocol for accurate diagnosis of coronary artery disease and (ii) demonstrate that a rapid MRI protocol produces diagnostic accuracy comparable to a standard, lengthy MRI protocol.